A Mixed Methods Examination of Mechanisms Underlying Sociodemographic Disparities Over the Transition to Adulthood Among Youth on the Autism Spectrum

NOT RELEVANT TO THIS SUPPLEMENT
This supplemental request is submitted in response to NOT-OD-21-070 (and NOT-OD-21-075). It is a request
for childcare costs to support Jenna Eilenberg, NRSA F31 Fellow. No changes to this project’s previously
approved scope of work are proposed. Please see field 28b of the Fellowship Supplemental form and the
Childcare Cost attachment in the Other Attachment Section of the R&R Other Project Information Form for
further details on that request.

Public health relevance
NOT RELEVANT TO THIS SUPPLEMENT This supplemental request is submitted in response to NOT-OD-21-070 (and NOT-OD-21-075). It is a request for childcare costs to support Jenna Eilenberg, NRSA F31 Fellow. No changes to this project’s previously approved scope of work are proposed. Please see field 28b of the Fellowship Supplemental form and the Childcare Cost attachment in the Other Attachment Section of the R&R Other Project Information Form for further details on that request.